Regulation of Intestinal Tight Junction Structure by Membrane Traffic

DESCRIPTION (provided by applicant): The establishment and maintenance of epithelial tight junction integrity is essential to the normal function of epithelial organs; above all, the ability of the intestinal epithelium to serve as a selective barrier to antigens and pathogens while absorbing nutrients is fundamental to intestinal function. Also, tight junctions together with associated polarity complexes are critical for the maintenance of epithelial polarity. Our investigations of epithelial development and polarity have focused on the endosomal protein, endotubin. Endotubin is an integral membrane protein that is resident in apical endosomes of polarized epithelial cells. It is expressed at high levels in developing intestine, particularly when the enterocytes are establishing polarity. Moreover, endotubin regulates junctional integrity and epithelial polarity, possibly through interaction with aPKC and Rab14. In this proposal, we will elucidate the mechanism of action of endotubin and Rab14 in the establishment and maintenance of epithelial tight junctions and polarity. Experiments outlined in this proposal will define the role of endotubin and Rab14 in targeting of junctional and apical proteins and elucidate the motifs of endotubin critical for the establishment and maintenance of epithelial junctions. Our hypothesis is that endotubin serves as a scaffolding protein to organize and target junctional and polarity proteins from the apical endosomes. Loss of endotubin function could result in loss of barrier function and/or apical-basolateral polarity, leading to compromised immunity in the newborn, increased susceptibility to inflammatory bowel disease, and/or cancer.

Public health relevance
Maintenance of epithelial cell tight junctions is essential for intestinal epithelial barrier function. Understanding the role of membrane trafficking in the generation and maintenance of tight junctions is fundamental to our understanding of intestinal development, normal function, and pathology.